Sensing Collimator Technology for Ultrasensitive SPECT Imaging of Targeted Radiopharmaceutical Therapies

Project Summary
This application addresses critically unmet needs in the field of targeted radiopharmaceutical therapy, an
emerging treatment paradigm for metastatic cancers. Therapeutic radiopharmaceuticals localize to and deposit
cytotoxic beta and alpha particles at sites of disease. Despite the great potential of these cytotoxic emitters, a
one-size-fits-all approach is used to determine administered activities that ignores features of an individual’s
disease phenotype. Precision and personalized dosimetry is a long-sought goal that is complicated by the
inherently low imaging signal produced by these therapeutic radionuclides and low administered activities used
for these drugs. For example, in contrast to diagnostic procedures, the administered activities of alpha particle
therapies are in the 100 µCi range, orders of magnitude lower than a typical SPECT or PET imaging agent; and
isotopes of interest (Actinium-225, Radium-223 and Lead-212) release only 5% of their decay energy by photons.
At such low photon fluxes, it is crucial to collect as many photons as possible in order to reconstruct accurate,
precise, and high-resolution imaging data. Conventional SPECT systems employ a lead collimator (to provide
positional information) in front of a NaI(Tl) crystal based camera (with optimal sensitivity for the detection of
~140keV photons). Such a device is sufficient for diagnostic imaging with Tc-99m despite rejection of 99% of
incident photons. Here, we develop a novel imaging detector module in which the collimator section is composed
of active sensing detectors to provide spatial and directional information without rejecting photons. Predicated
on extensive preliminary data and proof of concept prototype detectors we put forwards a mathematic framework
using accurate physics and state-of-the-art anthropomorphic models to optimize this Sensing-Collimator Imaging
(SCI) SPECT technology. We rigorously validate and evaluate this platform in order to develop the next
generation SPECT imager that can reliably measure the distribution of therapeutic radiopharmaceuticals with
orders of magnitude greater sensitivity and innovate the field towards the goal of direct, sensitive, and accurate
imaging of alpha-emitting targeted radiopharmaceutical therapies.

Public health relevance
Project Narrative This application undertakes the development of a novel high sensitivity imaging technology. Using a novel sensing collimator detector design, computational models, physical phantoms, we optimize and validate a new paradigm for SPECT imaging. Our long-term goal is to employ this technology to detect and image the distribution of ultralow photon fluxes in patients receiving alpha particle therapy.